Integrated Data and Exposure Analytics (IDEA) Core

Project Summary - Integrated Data and Exposure Analytics (IDEA) Core
The overall goal of the Integrated Data and Exposure Analytics (IDEA) Core is to coordinate and facilitate
research and training across the Climate and Health: Action and Research for Transformational Change Center
(CHART). This will be achieved by supporting data systems and data science approaches to expedite study
design, data collection, analysis, integration, and dissemination; and by facilitating climate-related exposure
assessment, integration, and modeling activities. While the framework will be applicable for the long-term plan
of advancing climate and health-related research and training at Columbia University and beyond, initial setup
and focus will be on the two research Projects and the pilot studies that are to be funded through the Pilot Project
Program (P3). The Core activities will be organized around four interrelated but complementary aims; namely,
(1) providing statistical resources, data analysis capabilities, and reproducibility tools; (2) integrating and
enhancing data management and harmonization, sharing, and interoperability; (3) providing support on exposure
assessment, modeling, and integration; and (4) providing capacity building and training across CHART through
a well-designed workshop series and engagement of researchers and trainees focusing on climate and health.
Through these aims, the IDEA Core will be able to provide centralized oversight of study design, data analytic
approaches, data management and harmonization, software development and implementation as well as quality
assurance/quality control (QA/QC). It will also be able to foster data sharing and interoperability plans across
CHART and beyond. The IDEA core will support exposure assessment, modeling, and integration for the two
Projects and/or pilot projects, as well as relevant climate and health-related activities within CHART and beyond.
Another major function of the IDEA Core is Capacity building, mainly built around the workshop series that will
be run in coordination with the Administrative and Community Engagement Cores. IDEA Core activities will be
dynamic and nimble to reflect the evolution of CHART as well as developments in climate science and data
science broadly – in response to an active feedback mechanism across CHART. The Core is well positioned to
help in prioritization of CHART activities and will ensure quality control by continuous monitoring of analytic
strategies and adherence to standard operating procedures (SOPs) set by the projects. By ensuring proper study
design and analytic approaches are employed, data management protocols and operations are integrated across
all Projects and Cores, and appropriate exposure assessment and modeling techniques are utilized, the IDEA
Core will enhance CHART’s mission via quantitative input to transform climate and health research towards
actionable solutions through transdisciplinary and integrative collaborations.